The role of the nigrothalamic pathway in opioid-driven behaviors

Project Summary
Chronic pain represents a significant clinical problem, affecting up to 20% of the general population. Over-
prescription of opioid analgesics has led to the current opioid epidemic as these medications carry high abuse
liability due to the rewarding effects they produce. Thus, to improve treatment strategies for pain and opioid
dependence, it is necessary to uncover the neural mechanisms underlying these debilitating conditions. Opioid
reward has traditionally been thought to involve disinhibition of midbrain dopamine neurons by local GABA
interneurons. However, we recently found that GABA neurons with high expression of mu opioid receptors in the
substantia nigra pars reticulata (SNr), a brain region largely ignored in the reward and addiction fields, play a
critical role in heroin self-administration and relapse. Although SNr GABA neurons are known to form
monosynaptic connections with neurons of the ventromedial thalamus (vmThal) and my preliminary data suggest
that both regions play a critical role in opioid-driven behaviors, to date, there is no direct evidence of a causal
role of the SNr->vmThal pathway in opioid self-administration, relapse and opioid-induced analgesia. To address
this critical gap in our knowledge and uncover the novel circuitry underlying pain and opioid addiction, we will
combine mouse self-administration with optogenetics and chemogenetic ablations to selectively manipulate the
SNr->vmThal pathway. In Specific Aims 1 and 2 we will test the hypothesis that heroin self-administration and
heroin-primed drug seeking in are mediated by inhibition of SNr GABA neurons projecting to the vmThal, causing
disinhibition of postsynaptic glutamate neurons. In Specific Aim 3, we will determine whether the SNr->vmThal
pathway plays a critical role in opioid-induced analgesia, by using optogenetic activation/inactivation or
chemogenetic ablation of genetically defined neurons with caspase-3 neurotoxin in hot plate and tail flick assays.
Given that woman have higher rates of prescription opioid use than men, we will investigate sex differences in
heroin-driven behaviors. These experiments satisfy objectives of NIH Helping to End Addiction Long-term
(HEAL) Initiative by linking addiction and pain-related neural substrates and identifying novel circuitry involved
in both conditions from which millions of people suffer worldwide. Thus, the proposed research is clinically
relevant, as uncovering the neurobiology of opioid addiction and nociception, will set the stage for improving
treatment strategies that are desperately needed. Importantly, the proposed experiments are carefully designed
with the thought of providing undergraduate students at Colgate University with the unique independent research
experience involving cutting-edge techniques to enhance their scientific profile in preparation for careers in the
biomedical field.

Public health relevance
Project Narrative Rampant abuse of prescribed and illegal opioids has contributed to a national opioid crisis for which we have limited treatments. A better understanding of the neural mechanisms underlying opioid-driven behaviors is required to improve our treatment strategies. The proposed research will expand our understanding of midbrain neuromechanisms underlying opioid reward, relapse, and analgesia and ultimately, it will have a significant public health impact by uncovering new therapeutic targets in treatment of addiction and chronic pain, the debilitating conditions affecting millions of people worldwide.